A trial of Pharmacist management of Oral anticoagulation THerapy versus Enhanced usual CARe in the communitY for AF (APOTHECARY AF)

PROJECT SUMMARY
Atrial fibrillation (AF) is the most common heart rhythm disorder and a leading cause of stroke in the elderly.
Stroke related to AF is far more severe than stroke unrelated to AF. Oral anticoagulation (OAC) therapy is critical
for stroke prevention and improved survival in AF. However, despite wide availability of OAC and accessible
clinical guidelines and tools for identifying individuals with AF who stand to benefit from OAC, major gaps in the
delivery of appropriate OAC therapy persist – leaving a large proportion of persons with AF at risk for stroke and
its potentially devastating sequalae. The most reported types of gaps in delivery of OAC therapy include: (i) non-
prescription, (ii) inappropriate medication, or (iii) sub-optimal dosing. Novel solutions are urgently needed to
address the persistent gaps in the appropriate delivery of OAC therapy for persons with AF. Accumulating
evidence suggests that pharmacist-based interventions for managing chronic diseases can be highly effective,
sustained, with high potential for scalability and lead to greater adherence to guideline-directed targets and
improved outcomes. The potential for efficacy around AF care is especially promising, as pharmacist-led warfarin
anticoagulation clinics have been shown to improve therapeutic goals, patient satisfaction, and quality-of-life.
Recent advances in OAC therapeutics now allow for effective drug choices that are safer and more easily
administered than warfarin without the need for frequent monitoring. Thus, pharmacist-led interventions now
represent an even more tractable approach to effectively closing gaps in OAC therapy delivery for stroke
prevention in patients with AF. In this context, our first aim will identify potential pharmacist barriers to prescribing
OAC at the patient, prescriber, pharmacist, and community levels and assess pharmacist knowledge regarding
indications and type of OAC therapy in AF through administration of a survey instrument; second, we will evaluate
in a cluster randomized clinical trial, the efficacy of a pharmacist-led intervention versus enhanced usual care on
the delivery of guideline concordant OAC therapy for older individuals with untreated AF and high stroke risk
presenting to community pharmacies. In secondary analyses, we will examine the effect of intervention on patient
satisfaction, OAC shared decision-making, and on OAC adherence, health care utilization, and clinical events at
1 year. We will leverage our novel randomized trial population to also identify reasons for undertreated AF from
a patient perspective and explore the impact of these factors on the efficacy of the intervention and OAC
adherence. This proposed research will generate clinically actionable knowledge through an innovative and
potentially sustainable stroke prevention strategy enacted by pharmacists at the point of medication delivery.
Ultimately, these data may be used to shape policy regarding pharmacist-led management of chronic disease
providing much needed randomized trial data to support efficacy and reimbursement for these activities.

Public health relevance
PROJECT NARRATIVE Oral anticoagulation therapy is critical for stroke prevention and improved survival in patients with atrial fibrillation but markedly under-utilized. In our research program, we aim to better define potential barriers to appropriate oral anticoagulation prescription, from both the pharmacist and patient perspective, and propose a novel intervention to improve the delivery of stroke prevention therapy in individuals with undertreated atrial fibrillation by evaluating the efficacy of a pharmacist-led intervention on delivery of oral anticoagulation compared to enhanced usual care in the community. This research will generate clinically actionable knowledge through an innovative and potentially sustainable stroke prevention strategy.